Differential Diagnosis in Learning Disabilities

OVERALL: The Colorado Learning Disabilities Research Center (CLDRC) is a long-standing interdisciplinary, multisite research program that investigates the genetic and environmental etiologies, neurobiology, neuropsychology, classification, and outcomes of specific learning disabilities (SLDs) and related disorders such as attention/deficit-hyperactivity disorder (ADHD). The unifying themes of this proposal for renewal of the Colorado Learning Disabilities Research Center are (1) to continue to produce innovative and impactful basic science to understand the shared risk factors that explain why specific learning disabilities (SLDs) are so often comorbid with other SLDs and disorders such as ADHD and anxiety, and just as importantly to identify the specific factors which contribute uniquely to each SLD; (2) to explicitly integrate cutting-edge research with state-of-the-art clinical training, facilitating the development of project-based career-enhancing opportunities for CLDRC mentees, (3) to expand bidirectional engagement efforts with the community to remove barriers that prevent access to services, maximizing the impact of our Center for all individuals with SLDs and their families, and (4) to disseminate the results of the CLDRC effectively to all stakeholders, including families, practitioners, educators, other scientists, and policy communities.
In addition to our ongoing efforts to publish our results for the scientific community, the CLDRC continues to expand our efforts to translate and disseminate results from the CLDRC to broader audiences of practitioners, educators, and individuals with learning disabilities. The CLDRC infrastructure also provides an unprecedented opportunity for interdisciplinary mentorship and project-embedded career enhancement opportunities for the next generation of LD investigators. The Engagement Core describes the specific strategies we will use to continue to support and expand these opportunities for CLDRC mentees. In addition, one of our most important objectives over the next five years is to expand our bidirectional engagement efforts by integrating community members in contributing roles on all projects.
The most distal long-term research objective of the CLDRC is the development of a comprehensive model of LDs that is based on a complete understanding of LDs at the genetic, environmental, neurobiological, cognitive, behavioral, and instructional levels of analysis. This is a daunting challenge that cannot be accomplished by a single scientist or research lab working in isolation. Instead, this work will require the successful integration of diverse approaches and strategies. The ongoing and long-term objective of the CLDRC is to continue provide a place where this synergistic integration can occur to promote interdisciplinary LD research and to develop the next generation of interdisciplinary scientists and practitioners.

Public health relevance
NARRATIVE The Colorado Learning Disabilities Research Center (CLDRC) is a long-standing interdisciplinary, multisite research program that investigates the genetic and environmental etiologies, neurobiology, neuropsychology, classification, and outcomes of specific learning disabilities (SLDs).